Administrative Supplement for MASALA-2G Study

PROJECT SUMMARY/ABSTRACT
The purpose of this administrative supplement is to allow Dr. Nilay Shah to continue toward his path of
becoming an independent investigator of community and clinical cardiovascular disease prevention in the
South Asian American population, by enabling timely progress toward the research aims while he is on
parental leave and has primary childrearing and childcare responsibilities. South Asians experience a
disproportionately higher burden of atherosclerotic cardiovascular disease (ASCVD) at younger ages
compared to other race/ethnic groups, but little is known about antecedent cardiovascular health in 2nd
generation young adult South Asian Americans to inform early life prevention strategies in this risk-enhanced
group. In the parent K23 award, the research aims facilitate the creation of the MASALA-2G second generation
study, an offspring study to the Mediators of Atherosclerosis in South Asians Living in America (MASALA)
cohort who are predominantly 1st generation immigrant South Asians. MASALA-2G is a foundational
investigation in the cardiovascular health of the South Asian American population and aligns directly with the
National Heart, Lung, and Blood Institute mission and objective to promote the prevention of heart diseases in
diverse populations. The Specific Aims are to: (1) pilot the MASALA-2G study of cardiovascular health in 2nd
generation South Asian adults; (2) determine multi-level contributors to cardiovascular health and coronary
artery calcium in MASALA-2G participants; and (3) contextualize a cardiovascular health promotion behavioral
intervention for this population based on quantitative findings. For the training component, Dr. Shah proposes a
comprehensive research and multidisciplinary career development plan composed of formal coursework,
intensive mentorship, and experiential training in cohort management and community engagement in health
disparity populations, and advanced statistical methods for multi-level associations. The research and training
will occur at Northwestern University, which provides Dr. Shah with access to unparalleled infrastructure and
partnerships for research in the South Asian community, a multidisciplinary team of mentors and collaborators
with comprehensive relevant expertise, strong institutional support from the Division of Cardiology and
Department of Preventive Medicine, and training opportunities including in Northwestern’s Center for
Community Health and Clinical and Translational Sciences Institute. This administrative supplement is
submitted to support several personnel who will continue primary data collection and data analysis during Dr.
Shah’s leave and initial period of childrearing, which will facilitate continued progress during the supplement
period and ensure Dr. Shah’s transition back to full productivity after the supplement period. Ultimately, the
parent K23 research and career development award, with additional support through a critical life event period
via this proposal, will directly facilitate Dr. Shah’s transition to independent research for cardiovascular
prevention in South Asian populations.

Public health relevance
PROJECT NARRATIVE South Asian Americans are disproportionately burdened by atherosclerotic cardiovascular disease (ASCVD) at younger ages compared to other groups. 2nd generation South Asian Americans are hypothesized to have unique cardiovascular health profiles and risk factors compared to 1st generation immigrant South Asians. Characterizing and contextualizing antecedent cardiovascular health and its multi-level contributors in 2nd generation young South Asian American adults will provide fundamental new knowledge to adapt clinical and behavior modification prevention strategies to improve cardiovascular health trajectories and to reduce ASCVD disparities in this risk-enhanced yet understudied population.